Center for Appalachian Research in Environmental Sciences Administrative Supplement for Cost Extension

PROJECT SUMMARY – Overall
The University of Kentucky Center for Appalachian Research in Environmental Sciences (UK-CARES) will
establish an Environmental Health Sciences Core Center to enhance research capacity focused on major
environmental health impacts to air and water quality that have been implicated in environmentally induced
disease. This Center will provide advanced infrastructure and leading expertise, dedicated career development
and mentorship, and community-engaged interactions to facilitate innovative discovery and new understandings
of environmental factors in disease initiation, progression, and outcomes and their community impacts. The
central hypothesis is that toxic environmental agents are contributors to the disproportionately high incidence of
chronic diseases, e.g., cancers, cardiopulmonary disease, and metabolic disorders in Appalachian Kentucky
and that the impacts of early exposure are especially harmful. UK-CARES draws on a strong and diverse base
of environmental health science and community-engaged research to build environmental health research
capacity to meet the needs of communities in three Area Development Districts in southeastern Kentucky: Big
Sandy, Kentucky River, and Cumberland Valley. Center members bring notable strengths in environmental
health across four Research Interest Groups: Cardiopulmonary Diseases, Metabolic Disorders, Cancer, and
Child Health and Early Life Exposures. To achieve the Center’s goal, UK-CARES will: 1) establish a rich
research environment and a framework for transdisciplinary leadership and integrated infrastructure to facilitate
collaboration and efficient use of resources for research expansion and development of new scientific directions;
2) build research capacity in environmental health sciences by providing an outstanding intellectual environment
and advanced infrastructure to support innovation and community engagement; 3) recruit new talent and
facilitate career development of investigators whose research addresses critical issues in environmentally
induced disease through mentorship and structured career training activities; 4) develop multi-directional and
mutually beneficial communications and interactions with community residents, policymakers, and public
health/healthcare professionals to identify environmental concerns of target communities as a stimulus to new
research; and 5) bridge the gap between discovery of novel research findings and population-level awareness
and practice via community-focused science communication training. An Integrative Health Sciences Facility
Core, Analytical Core, and Community Outreach and Engagement Core are integral to this effort and will
catalyze multi-directional translation across the whole spectrum of research; provide advanced analytical
support in metabolomics, computational biology, analytical chemistry, biospecimen management, and
bioinformatics; and bridge Center and community priorities. Complementary activities in career development of
scientists who are interested in tackling challenging environmental health questions and pilot project funding will
support developing research and evolving scientific directions.

Public health relevance
PROJECT NARRATIVE – Overall The University of Kentucky Center for Appalachian Research in Environmental Sciences (UK-CARES) will enhance programmatic and scientific capacity toward the goal of facilitating innovative discovery and new understandings of environmental factors in disease initiation, progression, and outcomes and their community impacts. Further, the Center will foster career development of environmental scientists interested in tackling challenging environmental health questions facing the southeastern Kentucky region. UK-CARES will achieve this goal by providing advanced infrastructure and expertise, training and mentorship, and community-engaged interactions. Project Narrative Page 136